Discovery of Novel Broad-Spectrum Coronavirus Mpro Inhibitors

PROJECT 1 - ABSTRACT
The goal of this project is to discover novel broad-spectrum coronavirus main protease (Mpro) inhibitors. We
have already obtained promising first-generation Mpro inhibitors with desired potency and drug-like properties.
The first-generation Mpro inhibitors are rapidly progressing to clinical development. In the current application,
we will capitalize the success of the first-generation inhibitor to develop the second-generation inhibitor. In
anticipation of future coronavirus emergence, the second-generation inhibitor will have (i) activities against
viruses resistant to the first-generation inhibitor and (ii) a broader coverage against different coronaviruses. To
achieve this goal, we will pursue three aims: (i) identify the antiviral spectrum of the first-generation Mpro inhibitor
and evaluate the potential to induce resistance; (ii) discover and optimize a second-generation novel broad-
spectrum Mpro inhibitor to anticipate potential resistance and future pandemics; and (iii) advance our second-
generation broad-spectrum coronavirus Mpro inhibitor through preclinical development to deliver an IND-ready
clinical candidate.